Regulation and Targets of the DNA Damage Checkpoint

DESCRIPTION (provided by applicant): ABSTRACT During genotoxic stress, cells activate a pathway, called the DNA damage checkpoint, to signal that damage has occurred. The inactivation of this checkpoint pathway is associated with many types of cancer, especially lymphoma and leukemia. The great majority of these checkpoint genes are conserved from humans to yeast. In fact, many of these genes have human homologs implicated in tumorigenesis. This application proposes to examine the ways in which the DNA damage checkpoint impinges upon normal cellular physiology, and the repercussions of DNA damage when the pathway is not functioning correctly. We will continue our previous studies in which we identified proteins that are modified by phosphorylation and ubiquitination when cells are damaged. We will also expand upon these studies by determining the significance of these events and the mechanisms by which they alter protein function. PUBLIC HEALTH RELEVANCE: Project narrative. Cancer is the result of uncontrolled cell division and is often initiated by mutations resulting from DNA damage. In this proposal, we outline experiments that characterize proteins responsible for regulating cell division in response to DNA damage. In doing this, we can better understand how cancers arise and the characteristics of tumors that can be used to selectively target them.

Public health relevance
Project narrative. Cancer is the result of uncontrolled cell division and is often initiated by mutations resulting from DNA damage. In this proposal, we outline experiments that characterize proteins responsible for regulating cell division in response to DNA damage. In doing this, we can better understand how cancers arise and the characteristics of tumors that can be used to selectively target them.